Administrative

The administrative core of this program project, led by Dr. Kenneth Bayles, will provide the organizational
structure for the entire program project and will give leadership, oversight, and direction for the individual projects
and cores. The first specific aim of this core, to set and implement the programmatic goals for the program project,
will be achieved through regular interactions with each of the participants to monitor the progress and reinforce
the specific aims of each project. The second aim will be to assure that the participants of this program project
are communicating effectively by organizing regular meetings to promote the exchange of ideas and to ensure
that off-campus participants are fully integrated into this project. Developing the scientific program will be the
third aim focusing primarily on pursuing additional funding opportunities that will complement and foster the
continued growth of our program. The fourth aim will be to maintain a system for fiscal accountability and
resource allocation, ensuring that all budgetary issues related to this project are handled appropriately by trained
personnel who are experienced with NIH and UNMC policies related to grants administration. The fifth and final
aim will be to offer statistical support for all projects in the planning of experiments and interpretation of results.
This support will be coordinated by Ms. Fang Qiu in the Department of Biostatistics at the University of Nebraska
Medical Center, who will participate in regular meetings with the members of this program project. The successful
implementation of these specific aims will form a solid foundation of administrative support needed by each of
the scientific projects and will help to assure the continued success of our program.